Upright, Low-dose, High-resolution, 3D Breast CT

ABSTRACT
Dedicated breast CT can eliminate tissue superposition that contributes to false-positives and false-
negatives, and alleviates the need for physical compression of the breast. It provides for 3D images at
near-isotropic spatial resolution that allows for viewing the breast in any orientation without the need for
repeat acquisitions. It is an emerging technology, with only about five teams conducting research,
worldwide. In order to develop, evaluate, accelerate its clinical translation, and to facilitate the widespread
clinical adaptation of this technology, we are collaborating with GE Global Research to develop an upright
patient positioning geometry with advanced technological capabilities designed to eventually allow for
breast cancer screening, in addition to diagnostic imaging. The technological advanced proposed include
an x-ray imaging detector with reduced system (electronic) noise, data readout rates improved by a factor of
at least 2, and improved spatial sampling (pixel pitch) by a factor of 2 or more; a short-scan acquisition
trajectory with angular range not exceeding 270-degrees that will improve patient positioning; and, the use
of model-based iterative reconstruction techniques. All these technological advances are focused on
improving posterior coverage, reducing the radiation dose to the breast so that it is similar to a standard 2-
view mammography exam, and improving the visualization of microcalcifications; all with an aim of making it
suitable for breast cancer screening in the future. Importantly, the upright geometry allows for rapid clinical
adaptation as it allows for easy replacement of mammography and digital breast tomosynthesis systems,
even in small mammography rooms, and addresses the patient discomfort observed with the prone breast
CT. The research is broadly organized in two phases. In the first phase, all design factors and operational
parameters will be verified through physics-based numerical simulations and empirical studies using the
bench-top prototype system. In the second phase, we will conduct a clinical feasibility study that will recruit
subjects from two cohorts: BIRADS 4/5, and screening population, to determine if the advanced
technological approach using the upright, low-dose, high-resolution dedicated breast CT system improves
the diagnostic accuracy compared to digital breast tomosynthesis. To our knowledge, this will be first study
to directly compare digital breast tomosynthesis with dedicated breast CT. Thus, the proposed research will
develop an innovative design concept for unprecedented impact in breast cancer imaging that will enable
breast imaging without physical compression and at radiation dose similar to mammography. To our
knowledge a compression-free breast CT system incorporating the aforementioned features does not exist.

Public health relevance
NARRATIVE Mammography has demonstrated reduction in breast cancer associated modality and has been a valuable tool for detecting and diagnosing breast cancer, but requires vigorous breast compression and tumors in dense breasts may be missed. While digital breast tomosynthesis reduces tissue superposition, its performance is dependent on breast density. In this research, we will design, develop and clinically evaluate a new generation of breast CT that will use upright patient positioning similar to mammography, but without breast compression, and at radiation dose similar to mammography to provide full 3D images of the breast.